IMPLEMENTATION OF A CRYOGENIC RECEIVER

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This subproject (phase 3) is intended to implement a cryogenic receiver. For this receiver system we require a cryogenic low-noise amplifiers (LNA) for Ku and Ka frequency bands from a company (e.g. Spacek Labs, Inc.) with the reputation for building such devices for Radio Astronomy and space. The LNA input will be protected with a custom-built cryogenic receiver protector switch. The cryogenic LNA, switches, and probe-head will be mounted on a carrier plate, housed by the developmental cryostat. Components external to the cryostat include Ka-band transceiver, electronics presumably comprised of DSP-controlled ACERT BN2 pulse programmer, and the AP240-based data acquisition system.